Sex and gender differences in lupus - intersection between immunometabolism, epigenetic remodeling and cardiac involvement

Lupus is predominantly a female disease, however men with lupus frequently have more severe symptoms and
organ involvement including cardiovascular disease, a leading cause of death in lupus. Environmental and
gender differences such as sunlight exposure and vitamin D levels have also been shown to play a role in lupus
progression and cardiovascular disease. Differences in metabolic activity have also been suggested to contribute
to sexually dimorphic immune responses and autoimmunity. Our recent data in female lupus combining cardiac
imaging with metabolomic profiling has shown potential links between cardiac involvement and metabolic
reprogramming of lupus monocytes. This proposal investigates the hypothesis that sex biases in metabolic
activity of monocytes drives epigenetic reprogramming of monocytes, driving functional differences. Secondly, it
will address how sexually dimorphic responses to vitamin D contribute to monocytic reprogramming. As
epigenetic changes in monocytes is linked with cardiovascular disease (CVD), and given the prevalence of CVD
in both male and female lupus, this proposal will address whether sex-specific changes in metabolic and genetic
reprogramming drive phenotypic differences in lupus monocytes and ask how this relates to prevalence of CMD
and CVD using state of the art cardiac imaging.
Aim 1: Determine whether metabolic pathways differ in monocytes from male and female lupus patients.
We will address how sexual dimorphism in immune responses and immunometabolism in monocytes integrate
to affect outcome between male and female patients using metabolic, proteomic and flow cytometry approaches.
Aim 2: Determine how genetic reprogramming drives sexually dimorphic monocytic function in lupus.
Single cell next generation sequencing will be used to determine chromatin accessibility in monocyte subsets
and ask how this influences gene expression programs and functional differences in male and female lupus.
Aim 3: Assess relative risk of CVD in male lupus using non-invasive cardiac imaging techniques.
Cardiac imaging will determine prevalence of CVD in male and female lupus and correlated with metabolic
changes or gene expression patterns to determine sexually dimorphic responses that determine risk.
Impact: Determining whether metabolic reprograming and epigenetic remodeling are sexually dimorphic in lupus
monocytes will potentially impact treatment approaches as we enter an era where drugs targeting
immunometabolism as being trialed in lupus.

Public health relevance
Lupus is a systemic autoimmune disease that affects mainly women, but with disease severity worse in male lupus, with increased risk in developing cardiovascular disease. Our recent investigations into the role of monocytes in driving microvascular disease in female lupus has uncovered a link between altered metabolism in lupus monocytes and epigenetic remodeling, now recognized as a key player in development of cardiovascular disease. This proposal will how sex and gender specific differences in immunometabolism, regulation of gene expression contribute to monocyte function and how this correlates with cardiovascular involvement as determined by cardiovascular imaging.